Development of a Novel, Targeted Small Molecule Inhibitor of the Nucleoside Salvage Pathway to Treat Crohn's disease

PROJECT SUMMARY
Crohn’s disease (CD) is a chronic autoimmune disease in which cells of the immune system attack gut tissue
leading to diarrhea, fatigue, weight loss, fistulas, and an increased risk of colorectal cancer. CD affects up to one
million Americans and is a type of inflammatory bowel disease (IBD). CD is driven by CD4 T cells with a
significant role for TH1 and TH17 cells and additional involvement of B cells. Current therapies for CD can be
effective but suffer from high rates of primary and secondary failure and are associated with significant, and
sometimes severe, side effects. New safe and effective therapies are needed to treat CD. The
deoxyribonucleoside salvage pathway, with rate-limiting enzyme deoxycytidine kinase (dCK), salvages
deoxyribonucleosides from extracellular space to provide deoxyribonucleotides for DNA synthesis during rapid
cell proliferation as occurs in lymphocytes during CD. dCK activity can be measured non-invasively in vivo in
mice and humans using the PET radiotracers [18F]FAC and [18F]CFA, respectively. dCK activity is enriched in
lymphoid organs in mice and humans, is activated in lymphocytes during periods of disease in models of
autoimmunity, but is not required for normal healthy cells. Trethera has developed TRE-515, a first-in-class small
molecule inhibitor of dCK, with excellent in vivo pharmacokinetics and pharmacodynamics that is currently in
Phase 1 clinical trials for the treatment of solid tumors where it is showing mild side effects and signs of efficacy.
In previous work in the adoptive CD4 T cell transfer (ACT) model of IBD, we showed that dCK activity is
upregulated in the mesenteric lymph nodes during disease and correlates with disease activity. Treating ACT
IBD mice with TRE-515 starting at symptom onset led to a significant improvement in the gut length-to-weight
ratio (a measure of disease activity) and a decrease in histological measures of disease including inflammation,
gland loss, and edema. Mechanistically, TRE-515 decreased the levels of activated and effector memory CD4+
T cells in the mesenteric lymph nodes. In this study, TRE-515 was as effective at treating IBD symptoms as
standard-of-care comparator anti-IL-12/IL-23. This work builds on studies showing that TRE-515 can limit
disease in models of other autoimmune diseases including the experimental autoimmune encephalomyelitis
mouse model of multiple sclerosis and optic neuritis. These data strongly suggest that TRE-515 could represent
a novel, safe, and effective treatment for CD. However, additional preclinical studies are required including
further work to define the mechanisms through which TRE-515 limits disease in the ACT IBD model as well as
critical efficacy studies in a separate, CD-specific mouse model that incorporates additional aspects of CD not
present in the ACT IBD model. Aim 1: To further study how rapidly TRE-515 with a unique mechanism of action
blocks disease promoting immune cells in the ACT IBD model and compares to standard of care. Aim 2: To
quantify dCK activity in the lymphoid organs throughout disease in the SAMP1/YitFc CD mouse model. Aim 3:
To test if TRE-515 blocks immune activation representative of a CD flare in SAMP1/YitFc mice.

Public health relevance
PROJECT NARRATIVE Crohn’s Disease is a chronic autoimmune disease that affects one million Americans and causes diarrhea, fatigue, weight loss, fistulas, and an increased risk of colorectal cancer. Treatment options are limited, suffer from high rates of primary and secondary failure, and are associated with significant side effects including increased risks of infections and malignancies. Here, we will complete critical preclinical studies to evaluate a first-in-class deoxycytidine kinase inhibitor as a novel therapy for Crohn’s Disease.